Transcriptional mechanisms and melanoma

Abstract
Melanoma is a tumor of the skin that frequently metastasizes and causes many deaths annually. Although there
are effective therapies for melanoma such as checkpoint blockade or BRAF inhibitors, resistance mechanisms
are frequently activated. Immunotherapy has become a frontline treatment for metastatic melanoma, but only
20-30% of patients have long term benefit from the treatment. Resistance correlates to the number of CD8
positive T cells that have infiltrated the tumor. Epigenetic regulators that are mutated in melanoma are associated
with drug resistance to checkpoint blockade. Understanding the pathways regulated by these chromatin factors
will allow for better therapies. We have developed a rapid melanoma model using zebrafish and can model many
of the mutations associated with human melanoma. We have created stable transgenic fish with the CD8a
promoter driving fluorescent markers and generated primary melanomas in this line to live image the T cells as
they enter the tumor. Using this approach, we have found distinct behaviors of T cells that interact directly with
melanoma cells. Slow migrating T cells appear exhausted at the borders of tumors, whereas active faster moving
T cells interact with the melanoma cells. Based on human melanoma genetics defined by our clinical colleagues,
we plan to quantify this behavior in melanomas with mutations in epigenetic regulators such as ARID2 and G9a.
Preliminary data shows that G9a inhibition suppresses the enhanced tumor initiation by ARID2 deficiency. Other
regulators will be investigated based on human tumor genetics. The effects of these epigenetic regulators on T
cell migration into the melanoma will be assessed by live imaging using two photon microscopy. We will study
chromatin accessibility of these tumors using ATAC-seq and correlate the results with human tumor accessibility
as defined by our group. The correlation of live imaging with chromatin accessibility will help define the
mechanisms of resistance of these transcription factors and will provide preclinical information about G9a
inhibitors on ARID2 deficient tumors. We will create models with mutations in a variety of transcription factors
and epigenetic regulators, particularly those of interest to the other investigators on this grant. Enhancer
reporters will also be developed to examine target genes in the tumors and T cells. We also will study the
chromatin effects driven by BRAF treatment, focusing on the mechanism of resistance. ETV1, a gene that is
amplified in 8% of melanoma, is reorganized on chromatin to activate a network of genes that drive resistance.
ETV1 is known to be phosphorylated by MAPK and we plan to interrogate this mechanism using proteomics. By
screening an epigenetic chemical library, we hope to reverse the resistance network for therapeutic purposes.
We will also investigate the role of ETV1 in the recruitment of T cells to tumors. Our studies, greatly strengthened
by our collaborations with Dr. Fisher (G9a and mouse melanoma models), Dr. Liu (epigenetic analyses), and
Drs. Wucherpfennig and Rodig (immunological mechanisms and cell profiling) have great impact on the basic
mechanism of resistance and will lead to new therapies for the treatment of drug resistant melanoma.

Public health relevance
Narrative Melanoma is a devasting disease that eventually becomes resistant to effective therapies. Our studies using the zebrafish as a model of melanoma allows for live imaging of the tumors and we can evaluate many genes functionally for the inducing resistance. Several genes that are involved in DNA packaging and gene expression are mutated in melanoma and this confers resistance by regulating signaling in the tumor or the recruitment of the immune system, and evaluating the activity of these genes will lead to a better understanding of drug resistance in melanoma and could also lead to new therapies.